SPAD at Alaska Pacific University

1 SPAD for Alaska Pacific University
2 PROJECT SUMMARY/ABSTRACT
3
4 Under the global goal of providing the foundation for research administration support to
5 ensure that Alaska Native/American Indian professional in biomedical fields succeed in their
6 sponsored projects funding pursuits, Alaska Pacific University seeks to increase productivity of
7 sponsored programs activities; enhance biomedical research and training at APU; and enhance
8 faculty and student participation in biomedical research and research training programs,
9 especially among Indigenous students. As an Alaska Native-Serving institution with a unique
10 affiliation with the Alaska Native Tribal Health Consortium, the largest, most comprehensive
11 Tribal health organization in the United States, APU has very recently built an office of
12 sponsored programs. With emerging undergraduate research programs in biomedical sciences,
13 the institution is ideally positioned to leverage NIH SPAD support to further develop OSP into an
14 effective, efficient, and sustainable unit of support to the university research community.
15 Specific Aims/Objectives include: 1) increase # of proposal application submission and #
16 of awards over AY20 baseline; 2) enhance research community understanding of regulatory
17 compliance areas through training, education and development; and 3) enhance research
18 community understanding of/response to the Indigenous communities APU serves, conduct
19 training, education and development on the lifecycle of sponsored projects.

Public health relevance
SPAD for Alaska Pacific University PROJECT NARRATIVE In recognition of the need to enhance diversity in the biomedical research workplace, Alaska Pacific University’s SPAD project aims to increase the productivity of its new sponsored programs department to enhance biomedical research and research training for undergraduates. Achievement of the proposed specific aims will provide the foundation for research administration support to ensure that Alaska Native/American Indian professionals in biomedical fields succeed in their sponsored projects funding pursuits.